Binocular Coordination of Eye Movements

ABSTRACT
Developmental strabismus (ocular misalignment) remains one of the most prevalent clinical problems related
to the visual-oculomotor system in children. In addition to horizontal eye misalignment, a host of other
oculomotor disturbances are associated with strabismus and despite considerable work, the mechanisms
underlying some of the unique oculomotor properties associated with the condition are unknown. In aims 1 and
2 of this proposal, we focus on addressing how strabismic subjects orient their eyes to visual and non-visual
target stimuli within their environment. This is especially interesting in the strabismic subjects because of their
ability to choose either of their eyes to acquire the target. Fixation preference is thought to be driven by visual
suppression of information from portions of the retina. However, eye movements are also made to acquire non-
visual (eg: auditory) targets. What happens to fixation preference and fixation-switching behavior in strabismus
when no visual stimulus is available? Aim 1 involves comparative studies of fixation switch and fixation
preference when the stimulus to the strabismic animal is either visual or auditory. In aim 2, we propose single
unit recording studies of neurons in the superior colliculus (SC) to determine their role in fixation-switch
behavior in response to the visual or auditory stimuli. The SC is chosen as the target of investigation because
of its reported role in target selection and its role in orienting to visual and auditory stimuli and in multisensory
integration. Aim1 and Aim 2 studies will be performed in juvenile rhesus non-human primates previously
induced with a sensory form of strabismus by rearing them under special viewing conditions (optical prism
rearing) for the first four months of their life. In Aim 3, we propose to develop a new non-human primate
strabismus model that utilizes loss of eye muscle proprioception due to sectioning of the ophthalmic division of
the trigeminal nerve in infancy. The motivation to develop a new model is that despite considerable work, the
mechanisms underlying the development of strabismus, especially in those patients where there is no obvious
loss of binocular vision or extraocular muscle disruption, are unknown. Our hypothesis is that intact eye muscle
proprioception is also needed for development of proper ocular alignment. We will investigate the longitudinal
development of eye alignment in these animals and compare proprioceptive loss strabismus to that occurring
due to loss of binocular vision (optical prism strabismus). In summary, each of the specific aims in this project
is likely to significantly advance our understanding of strabismus mechanisms and the neural circuitry
underlying some of its properties. Moreover, this project has the potential to help guide the development of
rationally based therapies.

Public health relevance
PROJECT NARRATIVE Ocular misalignment (strabismus) is a developmental disorder that affects a significant number of children born every year in the United States and around the world. A better understanding of neural and peripheral mechanisms that are affected in the different forms of strabismus will help develop rationally based therapy. This project will a) combine various physiological methods and behavior investigation in an animal model to investigate how gaze is re-oriented to visual and non-visual (auditory) stimuli in strabismus b) develop and study a novel animal model (proprioceptive loss strabismus model) to shed new insight onto central and peripheral correlates to disruption of eye alignment in strabismus.